Targeting Ceramide Signaling: Enhancing Healthy Aging and Combating Tauopathy in Mammals

The study investigates the association between growth hormone deficiency and longevity in
mouse models. We discovered that GHRH-KO mice with extended lifespans have different
circulating lipid profiles, with ceramides being the most significantly altered lipid class.
Ceramides have been implicated in several pathways related to aging, including insulin
resistance, mitochondrial dysfunction, inflammation, apoptosis, and cellular senescence. The
study aims to determine the role of ceramides in regulating healthspan and lifespan in mice, and
to investigate the impact of genetic and pharmacological interventions that lower ceramide
levels. The research approach involves integrating the understanding of GH action and
ceramide signaling from the cellular and tissue levels to whole-animal outcomes. The results of
this proposal will provide new insights into the differential mechanisms of action and offer the
possibility of developing translational interventions. The proposed project is novel and has the
potential to revolutionize our understanding of mammalian aging and longevity.

Public health relevance
This research aims to explore the connection between growth hormone deficiency and longevity in mice, in order to better understand aging and age-related diseases. With the increasing number of elderly Americans posing a challenge to healthcare, the findings could lead to promising new anti-aging therapies that are both effective and cost-efficient.